Large Animal Models Core

PROJECT SUMMARY - LARGE ANIMAL MODELS CORE
The Large Animal Models Core was originally developed in 2014 because of the recognition that small animal
models have been inadequate to solving human health digestive disease problems. This is particularly true
where key human anatomical features are not present in small animals, or where the size of the animal is
important for model development. The core has developed models of Barrett’s esophagus and eosinophilic
esophagitis (EoE) that can be monitored repeatedly under anesthesia via a human gastroscope. The Core
has been involved in intestinal transplantation in the pig using intestinal storage devices developed for
humans and surgical techniques that mirror human size and techniques. Studies of epithelial repair following
ischemic injury may have implications for necrotizing enterocolitis.
The Core creates easy access for investigators. The Core staff submits IACUCs, arranges for housing,
schedules procedures, configures procedural space, and coordinates with other units such as imaging.
Animals are followed by Core veterinarians and lab animal veterinarians. These tasks are routine at the
College of Veterinary Medicine but would be impossible for investigators at Duke and UNC. The Core makes it
possible for them to conduct large animal research. Although the Core currently serves a small number of
members, it provides a remarkable scientific impact on their research which would not be possible without the
Core.
The specific aims of the core are:
1. To provide consultation with Core veterinarians to assess feasibility, logistics and study design thus
facilitating the development and approval of IACUC protocols.
2. To assist in the procurement of animals from NC State farms at a substantial savings
3. To provide access to animal procedures involving anesthesia including both endoscopy and surgery
with subsequent postoperative follow up.
4. To develop novel research technologies involving large animal models such as genetic manipulation.
The Core directors (Blikslager and Gonzalez) have a demonstrated track record in digestive disease research
and are board-certified veterinary specialists in surgery. Veterinary board-certified specialists in laboratory
animal medicine, internal medicine, anesthesia, and advanced imaging (MRI, CT, nuclear medicine) from the
NC State Veterinary Hospital have all provided consultation over the last 10 years. Their collaboration has led
to adaptations in anesthetic technique to resemble human procedures more closely, particularly post-
procedural management. Specialists provide pain management and close monitoring when animals are
returned to their housing to ensure optimal care using the Guide for the Care and Use of Agricultural Animals
in Research in AAALAC-accredited facilities.